Adverse Effects of Neonatal CPAP on Lung Development

Abstract:
Supplemental O2 therapy and non-invasive ventilation such as continuous positive pressure support (CPAP)
are two common life-saving modalities of respiratory care for the treatment of preterm infants with respiratory
distress. However, most methods of respiratory care contribute to major life-long unintended consequences
such as airway hyperreactivity (AHR) disorders associated with wheezing and asthma. Supplemental O2
therapy and invasive mechanical ventilation have long been recognized as primary contributors to the
pathogenesis of wheezing in former preterm infants – these observations have driven efforts to titrate and
minimize the usage of O2 in the NICU setting while favoring the use of non-invasive positive pressure support
such as CPAP. As a result, there is a growing number of preterm infants who receive CPAP and many without
supplemental O2. Although CPAP is on the gentler end of the spectrum of positive pressure modalities, know
very little is known about its effects on lung development. Emerging clinical evidence, however, implicates
CPAP in poor respiratory outcomes associated with restrictions in airflow and also wheezing in former preterm
infants into childhood. We have corroborated these findings using a novel mouse model of neonatal CPAP
which is sufficient, without hyperoxia exposure, to elicit AHR via a mechanism involving airway smooth muscle
proliferation – a phenotype functionally analogous to that seen with neonatal supplemental O2. We have also
demonstrated a role of airway smooth muscle (ASM) proliferation, Ca2+ signaling, and the extracellular matrix,
specifically low molecular weight hyaluronan (HALMW) in CPAP effects. Together with the limited clinical data,
these observations are at the forefront of identifying the potential adverse effects of CPAP and how it could be
a significant contributor to poor respiratory system development seen in former preterm infants. In this
application, we utilize the same in vivo mouse (CPAP) model, complemented with a human fetal ASM (fASM)
in vitro stretch model which mimics CPAP, to test the overall hypotheses that stretch-induced effects on ASM
proliferation and hyperreactivity are initiated by multiple mechanosensitive pathways involving: 1) the newly
identified piezo (PZ) family of mechanosensors; 2) extracellular matrix and stretch sensitive HALMW; and 3)
plasma membrane caveolae. A novel feature of this proposal is the identification of an apparent feedforward
mechanism by all three pathways, while distinctly different, converge and reinforce each other’s effects to
cause the persistent AHR. Therefore, this proposal will reveal novel mechanosensitive pathways as a primary
mechanistic feature of the unintended consequences of CPAP on airway hyperreactivity, with will be crucial in
guiding the clinical care of preterm infants in a way that minimizes the adverse effects of these respiratory
interventions and maximizing their benefits.

Public health relevance
Project Narrative: An immature poorly functioning lung is a common life-threatening complication faced by most premature babies. Supplemental oxygen and positive pressure respiratory support (e.g. continuous positive airway pressure, CPAP) are just two important therapies that are intended to assist the baby through the immediate postnatal period until the lungs can function properly. Many therapies, however, have life-long unintended side- effects. Supplemental oxygen, for example, can cause lung injury and predisposes the infant to asthma and wheezing later in childhood. Recently we have begun to see that neonatal CPAP could also have similar unfortunate side-effects. The primary goal of this proposal, therefore, is to use a mouse model of CPAP and fetal human smooth muscle cells to determine the effects of mechanical stretch airway, specifically smooth muscle cell development, and it contributes to wheezing. We propose that mechanical stretch imposed on the lung by CPAP activates stretch-sensitive mechanisms that cause the airways to become hyper-reactive, a characteristic feature of wheezing and asthma. The data from this proposal will be the first to offer some insight into how CPAP impacts airway reactivity and wheezing disorders in former preterm infants.